INDUCED APOPTOSIS &LIFETIME VALUE: ETHIDIUM BROMIDE BOUND TO RESIDUAL CHROMATIN

Fluorescence lifetime analysis was used in combination with conventional flow cytometric analysis to monitor changes in residual chromatin in apoptotic HL-60 cell populations following treatment with camptothecin, cycloheximide, genistein, H7, and gamma radiation. Data show that all of these metabolic inhibitors that act through different signaling cascades, produce apoptotic sub-populations with decreased, but different lifetimes for DNA-bound ethidium bromide (EB). Results indicate that lifetime analysis, in conjunction with conventional flow cytometry, can be useful for early detection of apoptosis-induced chromatin changes and can also potentially provide new information on the effects of different apoptosis inducing agents.